Molecular mechanisms of synaptic dysfunction and cognitive decline in Huntington's disease

PROJECT SUMMARY
Huntington’s disease (HD) is a neurodegenerative disease caused by a CAG repeat expansion in the HTT
gene that preferentially affects medium spiny neurons (MSNs) of the striatum. HD is primarily characterized as
a motor disease, but it also manifests with cognitive and behavioral deficits that appear well before motor
symptoms onset and are considered the most burdensome for patients and caregivers. Cognitive changes in
HD are most highly associated with functional decline and can be predictive of nursing home placement.
However, the etiology of cognitive decline in HD is significantly understudied. The goal of this proposal is to
provide a mechanistic understanding for how cognitive decline arises in HD. The dorsomedial striatum (DMS),
the most affected area in HD, has long been recognized as an important structure in the regulation of various
cognitive functions and its degeneration has been observed in patients with various forms of dementia. The
striatum’s function is regulated by two major excitatory glutamatergic inputs: thalamo-striatal (T-S) and cortico-
striatal (C-S). T-S synapses contribute to the regulation of cognitive flexibility, working memory, and some
forms of learning, and are preferentially lost in young HD mice. Studies in HD patients before-clinical motor
diagnosis found a strong thalamus–striatum association that significantly co-varies with cognitive performance
and is predictive of cognitive impairment and disease progression. During the prior research period, we
established a connection between the stability of T-S synapses and Heat Shock transcription Factor 1 (HSF1),
a protein known for its role in protein homeostasis and stress response, in both physiology and HD. In the
renewal of this R01 we are seeking to understand how HSF1 participates in the early loss of T-S synapses in
HD and whether T-S synapse loss leads to cognitive decline in HD. Our preliminary HSF1 ChIP-seq analyses
in young zQ175 HD mice revealed a deficit in HSF1 DNA binding onto specific postsynaptic scaffolding genes
involved in synapse maintenance and HSF1 RNAi injected in the striatum of WT mice mimicked decreased T-S
synapses and impaired cognition as seen in HD mice. Our previous proteomic work also revealed HSF1
interacts with unique proteins in HD that negatively influence HSF1 activity. We hypothesize that HSF1
interacts with unique proteins in HD that impair HSF1 binding and regulation of genes involved in the formation
and maintenance of T-S synapses, causing T-S synapse loss and cognitive decline. We will test this
hypothesis by 1) investigating the mechanism responsible for the alteration of HSF1 DNA-binding in early HD,
2) assessing how HSF1 regulates the synaptoproteome of T-S synapses, and 3) evaluating the role of HSF1-
mediated loss of T-S synapses in the dysregulation of striatal synaptic plasticity and cognitive deficits in HD.
Successful completion of our work will shed light into the mechanisms responsible for cognitive decline in HD
and perhaps other forms of dementia in which HSF1 and DMS dysregulation have been observed.

Public health relevance
PROJECT NARRATIVE Although Huntington’s disease (HD) is considered a motor disease, cognitive symptoms are the most burdensome for patients and caregivers, are strongly associated with functional decline, and can be predictive of nursing home placement. Understanding the neurobiology behind cognitive decline in HD is crucial to improve the quality of life of HD patients. Our proposal aims to find a mechanistic understanding for the decline in cognitive function in HD and explores potential therapeutic targets for the improvement of cognitive symptoms in HD.